Molecular control of translesion synthesis fidelity beyond the lesion

Project Summary – Maintaining active high-fidelity replication despite a constant barrage of DNA damage or
blocks that are encountered by the replisome requires several inherent genomic protective functions. An
immediate first ‘on-the-fly’ response can be the recruitment of translesion synthesis (TLS) DNA polymerase to
directly bypass damage that stalls a high-fidelity (HiFi) polymerase. However, this process is complex and
multidimensional and requires separate substitution events that can recruit one of several TLS polymerases,
facilitate insertion opposite the lesion and beyond, and then substitute back to the HiFi polymerase. Although
TLS polymerases have generally accurate insertions opposite cognate lesions, their fidelity opposite
undamaged DNA must be restrained to prevent downstream mutations giving rise to cancer initiation. The
kinetic and structural mechanisms for TLS insertions have been widely studied, providing a wealth of
information on lesion specificities; however, these results are primarily derived from truncated core polymerase
enzymes that lack N- and C-terminal domains important for interacting with replisome components to facilitate
TLS substitutions. Moreover, the molecular and structural mechanisms to limit downstream synthesis after
insertion by TLS polymerases are unexplored. We hypothesize that intrinsic contacts outside the active site of
TLS DNA polymerases restrict synthesis downstream of a lesion to maintain genomic fidelity. To test this
hypothesis, we will validate our preliminary data showing that specific ‘pink-trigger’ residues in TLS
polymerases sense synthesis at distinct positions past lesions to kinetically promote dissociation. Utilizing
primarily full-length human DNA polymerase enzymes, accessory factors, and stabilizing bridges, we will
characterize the substitution steps needed to bypass several cognate lesions, validating important contact
points that help recruit, synthesize past, and enable reinstatement of HiFi DNA polymerases. The proposed
research program is highly integrated using advanced biochemical, enzymological, kinetic, and structural
approaches to better understand the entire TLS process and will be performed by several excellent
undergraduate and graduate student researchers providing a significant health science training opportunity at a
primarily undergraduate university. Results from this proposal will provide a clearer understanding of the steps
and contacts required to perform efficient TLS but also restrict downstream low-fidelity synthesis past template
lesions. Conclusions from these studies will be influential in providing insights into patient mutations leading to
cancer and rapid aging as well as identifying novel targets to prevent chemoresistance.

Public health relevance
Project Narrative – To ensure genomic integrity, it is essential that DNA synthesis is efficient and error-free, and that DNA damage is bypassed quickly to maintain an active replisome. Therefore, cells have evolved several translesion DNA polymerases to respond to different lesions with limited processivity. Substitution of a high-fidelity polymerase for a translesion polymerase are multidimensional and rely on specific contacts for the initial recruitment, insertion, and extension processes; however, the molecular mechanisms for these events are unknown.